C1: Administrative

Project Summary/Abstract: Core 1, Administrative
The Administrative Core will facilitate team cohesion and provide support for all the research projects and
resource cores in this multi-component U19 program. In particular, the core’s administrator will support the
team director and the Internal Advisory Committee as they supervise budgets and scientific activities. The
first aim of this core will be to manage research teams to foster synergy across projects and laboratories.
That goal will not be very challenging because the investigators in this proposal have worked together as a
U19 team for four years and have a strong history of collaboration over the past eight years. Coordination of
the research projects and other resource cores is the highest priority of the Administrative Core, and the team
director takes it as part of his mission to make sure that all investigators and students of each project are well
informed of the activities in other projects and of relevant new findings in the field. An Annual Meeting will
include the project leaders, students, and postdocs, along with an External Advisory Board. This core’s
second aim is to organize the planning and evaluation of research projects, including fiscal oversight. By
supporting planning, coordination, and regulatory compliance, the Administrative Core will allow PIs,
postdocs, and students to focus on their research without spending excessive amounts of time puzzling out
paperwork. Overseeing the finances of a large collaboration involves a substantial management and
reporting effort, which the administrator will help to alleviate by producing monthly, quarterly, and annual
budget reports for the team director to review. Another task that involves significant administrative work is
personnel recruitment and management. The administrator will help to schedule interviews for job
candidates, meet reporting requirements, book travel, and acquire major supplies and equipment, as well as
strengthen ongoing outreach activities to ensure an even more diverse applicant pool. The third aim will be to
support outreach to other research groups and to the public, including disseminating the methods, tools, and
results of this research. The collaboration has its own website, which the administrator will update,
highlighting the team, projects, publications, and alumni. The administrator will also design and implement
outreach activities, such as public lectures and workshops, that translate how scientific findings on
decision-making and working memory relate to daily life. By managing these resources and activities, the
Administrative Core will help the team director to coordinate the five research projects and the four resource
cores, allowing project leaders and other research personnel to concentrate on their strengths in research.
This work will contribute substantially to enabling the U19 team to achieve its overall goal of determining the
neural basis of working memory and decision-making.